Neural Mechanisms Promoting Biased Social Memories in Intergenerational Childhood Abuse

PROJECT SUMMARY/ABSTRACT
Childhood maltreatment impacts over a third of children worldwide and contributes to a quarter of all psychiatric
disorders. Because parents with, compared to without exposure to childhood maltreatment are 2-3 times more
likely to abuse their own children, many families are trapped in intergenerational cycles of abuse. Although
intergenerational abuse is well-established, the cognitive mechanisms that contribute to its persistence are
poorly mapped. We propose that childhood abuse may bias individuals towards prioritizing the encoding and
recall of negative, rather than positive, social feedback. Despite robust evidence that childhood abuse is
associated with negative cognitive biases as well as alterations in episodic memory and corresponding
hippocampal dysfunction, the role that memory bias plays in intergenerational abuse remains untested. Because
memory is reconstructive, it is fundamentally malleable, thus neurocognitive mechanisms of memory bias may
serve as an ideal intervention target. One factor contributing to a dearth of research testing effects of memory
bias on abuse transmission is a lack of ecologically-valid paradigms that link brain response to encoding social
feedback with its subsequent recall. We addressed this challenge with the Recall After Feedback Task (RAFT).
Preliminary work with the RAFT demonstrates that more severe childhood abuse is associated with greater recall
for negative social feedback and enhanced anterior hippocampal engagement when encoding negative vs.
positive social feedback. I propose to extend this work in parents with a range of childhood abuse experiences
and test the extent to which neurocognitive mechanisms implicated in social memory bias relate to current harsh
parenting style. This inquiry is essential given that abuse is an inherently social process, yet most studies of
intergenerational transmission fail to probe neurocognitive mechanisms that support social processing. I aim to
characterize associations between childhood abuse and 1) memory bias for social feedback; 2) the relationship
between hippocampal activation when encoding social feedback and memory bias; and 3) the degree to which
memory bias and brain activation promote harsh parenting. The proposed study will advance the field and
provide novel intervention targets by characterizing the contribution of social memory bias and its neural basis
to the link between childhood abuse and harsh parenting. The proposed training plan, which consists of
workshops, experiential learning, and mentorship, will develop my expertise in ecologically-valid fMRI study
design and analysis, neural mechanisms of memory, and neuropsychosocial outcomes following maltreatment.
As a result, I will gain expertise and preliminary data needed for future grants that inform interventions to curtail
intergenerational abuse and establish the foundation for becoming an independent developmental social
neuroscientist. Temple University’s Department of Psychology and Neuroscience has a successful track record
of conducting impactful NICHD-funded work and is the ideal setting for the proposed research and training.

Public health relevance
PROJECT NARRATIVE Childhood abuse is associated with devastating public health outcomes and is often transmitted intergenerationally from parent to child. Because child abuse is a product of interpersonal experiences, pinpointing targets for disrupting these cycles requires the study of social processes. The proposed study uses a novel fMRI paradigm to quantify memory biases and brain function when encoding social feedback, and explores whether these neurocognitive mechanisms may link exposure to childhood abuse with subsequent harsh parenting.